Signaling Mechanisms and Cellular Functions of a Ciliopathy-associated Protein Kinase

Abstract
Ciliopathies comprise an expanding group of human disorders associated with genetic mutations causing cilia
dysfunction. The primary cilium is a microtubule (MT)-based organelle that protrudes from the apical surface of
nearly every mammalian cell and plays a critical role in chemical sensation, signal transduction, and control of
various cellular functions. To date, there are still major gaps in our knowledge about the dynamic structure and
function of the primary cilium, and the underlying molecular basis of ciliopathies. Our research project is
focused on elucidating the molecular mechanism by which pathogenic mutations in the human CILK1
(ciliogenesis associated kinase 1) gene cause ciliopathies. Our research will exert strong impact on basic
knowledge about the primary cilium and significantly advance our understanding of the disease mechanisms
underlying human ciliopathies.
Western blotting is the most frequently used method in our experimentation and the quality of Western blots is
essential for the success of this project. In this supplement, we request the purchase of Amersham
ImageQuant™ 800 Western blot imaging system to replace an outdated film processor in order to meet our
need to achieve high sensitivity and accurate quantification for both chemiluminescence and multi-channel
fluorescence signals on Western blots.

Public health relevance
Project Narrative Human ciliopathies comprise a wide spectrum of human diseases caused by defects in the primary cilium, a cellular organelle that senses and integrates responses to environmental cues. Due to major gaps in our knowledge about ciliary structure and signaling, the molecular bases of ciliary dysfunction in many ciliopathies remain obscure. Our proposal is aimed at elucidating the signaling mechanism of a ciliopathy-associated protein kinase and advancing our understanding of the basic mechanisms underlying human ciliopathies.